A BRAIN Initiative Resource: The Neuroscience Multi-omic Data Archive

PROJECT SUMMARY
The Brain Research through Advancing Innovative Neurotechnologies (BRAIN) Initiative
promotes the development and application of technologies to describe the temporal and spatial
dynamics of cell types and neural circuits in the brain. The Principal Investigator, senior
personnel and staff of this project have diverse expertise required to marshall data across the
BRAIN Initiative consortium, including experience in data collection from multiple institutions,
large-scale quality control and analysis processing capability, familiarity with NIH policy and
public archive deposition strategies. We have developed the Neuroscience Multi-Omic Archive
(NeMO Archive), a data repository that is specifically focused on the storage and dissemination
of omic data from the BRAIN Initiative and related brain research projects. Our site utilizes a
federated model for data storage such that the physical location of data can be distributed
between the NeMO local file system, public repositories, and a cloud-based storage system
(e.g. Google Cloud Platform). This supplemental request is to ensure that previously
unanticipated volumes of data generated by the BRAIN research community are hosted,
processed and shared across the NIMH data ecosystem.

Public health relevance
PROJECT NARRATIVE The Neuroscience Multi-Omic Archive (NeMO Archive) is a data repository that is specifically focused on the storage and dissemination of omic data from the BRAIN Initiative and related brain research projects. The Archive and accumulated over 700 TB (~2.7 million files) of unrestricted transcriptomic and epigenetic sequence data from mouse, human, and marmoset of which users have performed cumulative downloads of over 380 TB. Roughly 5-fold more data than was originally budgeted in our NeMO application is expected to be generated by members of the BRAIN Initiative, which requires that we request an additional supplement to support the research community.